Auto-calibrating, Air Quality Monitoring System

Project Summary: In 2021, chemical manufacturing industries accounted for roughly 529,000 workers, and
“Extraction” accounted for 226,840 workers in the U.S. oil & gas industry. With projected growth rate of 3.8%
annually in the U.S. oil and gas industries, worker exposures to harmful levels of petrochemicals are likely to
increase. From 2003-2015, this industry reported 148 fatal injuries from exposures to “chemicals and chemical
products.” Long-term worker exposures are not well tracked, and monitoring only occurs after a problem or
illness is identified. To help address this deficiency, Seacoast proposes to develop a fully automated indoor air
quality (IAQ) analyzer with speciation capability. Seacoast's analyzer, the SeaPort AQ, combines a low-cost
detector, two trap-and-purge, thermal desorption collectors for signal amplification, and the separation and
resolving power of gas chromatography to (1) collect and analyze air in its immediate environment, (2) provide
wirelessly networked data to industrial hygienists to track workplace exposure, (3) reduce the per-sample
analytical costs by automatically including calibrations without user intervention. Remote programmability will
provide low per-sample costs and the ability to track chemicals around the clock.
In Phase I, Seacoast assembled and demonstrated a low-cost, chromatographic analyzer to speciate benzene,
toluene, ethylbenzene, and xylene (BTEX) at levels well below the OSHA 8-hr (TWA) action level (500ppb) for
benzene. We demonstrated automated field-blanks, calibration, and ambient air sample collection. We integrated
an oven-less gas chromatography (GC) column specifically tailored for high resolution separation of BTEX from
interfering compounds common to petrochemical and related industries. The analyzer uses a high-sensitivity
chemical detector for hydrocarbons, which is insensitive to humidity and CO2. Miniature valves on custom
designed manifolds eliminated the need for a bulky, expensive rotary valve, allowing the analyzer to cycle
through collection, purges, and re-calibrations autonomously to verify analyzer performance.
The Phase I prototype exceeded our proposed goal to sample and detect benzene at 50 ppb in under 30 minutes,
demonstrating collection and detection of ~5ppb of benzene in less than 30 minutes. Seacoast's air quality
analyzer can finally provide hourly vapor concentration tracking data, a vast improvement over weekly or monthly
data to improve exposure or pollution tracking models at a per-sample cost of ~$1.
In Phase II Seacoast will complete materials and system optimization and construct robust prototypes for field
testing by two experts in the two primary industries interested in air monitoring: industrial hygiene and
environmental pollution mitigation. These experts will perform side-by-side comparisons of our prototype and
conventional systems, and field tests at contaminated environmental sites where BTEX and other chemical
pollution is known to be present at elevated concentrations in the air.

Public health relevance
PROJECT NARRATIVE – “Auto-calibrating, Air Quality Monitoring System” This proposal describes a novel use of low-cost microsensors to develop a compact, chemical detector to help protect workers from inhalation exposure of harmful chemicals. Seacoast Science, Inc.'s detector tracks room air levels of vapor hazards, even when vapor concentrations are below OSHA action levels, thereby supporting workplace OSHA standards. The analyzer will detect chemical vapors common to a wide range of high-risk occupations, including workers in the oil and gas, painting, metal working, and hazard remediation industries.